Mechanisms of Lipid Droplet Formation

No changes from original submission
Project Summary/Abstract
Lipid droplets (LDs) are ubiquitous monolayer-bound organelles that function in cellular lipid storage (for metabolic
energy or membrane synthesis). LDs form from the ER, but how LDs are formed remains unknown and is a central
question for the field. The current model indicates that neutral lipids, such as triacylglycerols (TG), are synthesized
in the ER and released into the bilayer. At a critical concentration, TGs de-mix from the phospholipid bilayer in a
phase transition that forms nascent LDs that bud toward the cytosol. We hypothesize that proteins are essential to
ensure this process occurs in a defined manner and to prevent the formation of “ectopic” and potentially
dysfunctional LDs, disrupting ER and cell function. Specifically, two ER proteins – seipin and lipid droplet assembly
factor 1 (LDAF1) – operate in the lipid droplet assembly complex (LDACs) in the ER to form LDs. Both proteins
form an oligomeric assembly with seipin forming a ring of 10-12 subunits and an equal number of LDAF1 occupying
the middle of the ring. While we have identified components of the LD formation machinery and gained some insight
into their structures, how these proteins function to facilitate LD formation remains mostly a mystery. Here we
propose to utilize the latest tools and approaches, including biochemistry, structural biology, molecular simulations,
and cell biology, to address the following questions: How and where is TG made relative to LDACs? What are the
molecular structures of the seipin/LDAF1 LDACs? How do these oligomeric complexes assemble/disassemble?
Where do LDACs localize in cells? How do they function to organize LD formation? We will address these questions
by completing four specific aims. Aim 1 will address the mechanism of TG synthesis in the ER by the DGAT1
enzyme. We will expand on our recent elucidation of the molecular structure of human DGAT1, combining molecular
dynamics and biochemical experiments to elucidate the precise mechanism of TG generation and determine how
TG is released into the ER membrane for LD formation. Aim 2 will determine how and where LD assembly
complexes assemble in cells to form LDs. We will determine the relationship of TG synthesis to LDACs, whether
seipin/LDAF1 LDACs localize to ER tubules and how they assemble. Aim 3 will focus on elucidating the molecular
structure of the seipin/LDAF1 LDAC in vitro and in cells. We will utilize cell and structural biology approaches,
including cryo-EM and cryo-ET to test the hypothesis that seipin and LDAF1 form a ring structure with LDAF1 in
center and that these LDACs form at areas of membrane curvature (tubules) where the structure may adopt dynamic
conformations and activate of the complex. Aim 4 will determine the molecular function of the seipin/LDAF1 LDAC
in vitro and in molecular dynamics simulations. We will reconstitute LD formation to test the hypothesis that the
seipin/LDAF1 LDAC catalyzes phase transition of TG in the membrane, ensuring LDs form at these designated
formation sites. Successful completion of these aims will advance the molecular understanding of a fundamental
process central to energy metabolism and provide information on the mechanistic underpinning of many metabolic
diseases, such as obesity, atherosclerosis, and fatty liver disease.

Public health relevance
No changes from original submission Project Narrative We are studying the basic biology underlying the formation of fat droplets in cells. This process is critical to meet the demands in cells for metabolic energy, but when uncontrolled leads to obesity, type 2 diabetes, fatty liver disease, and other metabolic diseases of fat excess. By understanding how these processes occur and are regulated, our work will advance our understanding of these conditions and may lead to new therapies to treat them.